Novel pro-healing scaffolds for cell therapies

Project Summary/Abstract
Strategies to promote wound healing and support engraftment of cell transplants may ultimately lead to
effective treatments for many degenerative diseases. Yet, to date control over insufficient or pathologic
revascularization of transplants, damaging inflammation, and/or dysregulated tissue differentiation remains
difficult to achieve solely by pharmacologic treatments. The transplant microenvironment by its own imparts
many constrains, i.e. cell transplants may need to adapt to sites of implantation that not always recapitulate the
cellular composition, molecular and/or physical properties of the organ of origin, all factors impacting on grafts
long-term survival and function. The rapid progress in tissue engineering technologies capable of reconstituting
structural and molecular cues mimicking native tissue microenvironments offers new opportunities to overcome
these limitations.
In this multi-investigator project, we integrate complementary areas of expertise on vascular biology,
cellular immunology, pancreatic tissue and stem cell biology, as well as bioengineering of novel biomaterials to
address a) pro-repair functions of novel biochemical cues (Slit-2 and Netrins) that we have identified in the
developing pancreas as critical regulators of endocrine differentiation and modulators of vasculogenic/immune
activities, and b) the functional impact of recapitulating in injury settings mechanical cues that we have
measured in the developing and adult human pancreas. To implement these studies we will adopt an
innovative bioengineering approach that allow for spatial patterning and temporal modulation of Slit and Netrin
proteins in vascular networks and extra-vascular spaces, as well as for pharmacologic control of tissue
stiffness. Based on preliminary studies supporting feasibility, we plan to dissect repair mechanisms dependent
on these biochemical and physical cues, and ultimately their impact on endocrine responses to metabolic
changes as read-out of grafts function. We will focus on the following aims:
Aim 1: To investigate the impact of Slit-2 engineered in PEG-based scaffolds on the revascularization and
immunomodulation of tissue grafts.
Aim 2: To assess the effects of Netrin-functionalized scaffolds on the differentiation and function of immature
tissue progenitors.
Aim 3: To address the impact of tuning the mechanical properties of support scaffolds on tissue progenitors
growth, differentiation and functional maturation.
Collectively, results from this collaborative project will establish the ground-work for the development and
production of a new generation of clinically-relevant scaffolds that will be relevant to a wide range of medical
conditions requiring cell replacement therapies and/or tissue regeneration.

Public health relevance
Project Narrative This project integrates complementary areas of expertise on vascular biology, cellular immunology, cell transplantation, and bioengineering of material sciences to develop a novel customizable biocompatible hydrogel scaffold that will support rapid revascularization, wound healing, and long-term in vivo survival and function of cell transplants. Unique innovative aspects of our approach include: high biocompatibility and lack of cytotoxicity, customizable bio-functionalization with moieties that enhance angiogenesis and revascularization, promoting cell differentiation of tissue- and stem cell-derived progenitors, and the ability to incorporate immune regulatory cues that will restrict immune cell recruitment at the site of implantation. We anticipate that results from our studies will lead to the production of innovative and clinically-relevant scaffolds for implementing cell transplantation therapies and/or strategies that foster tissue regeneration and healing in a wide range of biomedical applications.